AUTONOMIC CARDIOVASCULAR RESPONSES IN THE ELDERLY WITH IMPAIRED BLOOD PRESSURE

The purpose of this study is to elucidate the mechanisms causing impaired blood pressure regulation in elderly patients with hypertension and/or postural hypotension. The focus of investigation is the mechanism of so called "physiologic" orthostatic hypotension.